Targeting NQO1+ tumor to trigger innate and adaptive immunity

ABSTRACT

Our long-­term goal is to develop novel antitumor therapies to treat cancer with elevated (> 100-­fold) levels of
NAD(P)H:quinone oxidoreductase 1 (NQO1). β-­Lapachone (β-­lap), an NQO1 bioactivatable drug, selectively
targets NQO1+ tumors and is activated by NQO1 to generate reactive oxygen species (ROS), leading to
extensive DNA damage and PARP1-­driven tumor programmed necrosis. Our preliminary studies demonstrate
that both neutrophil-­mediated innate immunity and CD8-­mediated adaptive immunity are required for antitumor
efficacy of β-­lap in vivo. Furthermore, our previous studies reveal that targeting NQO1 potently triggers innate
sensing within tumor microenvironment (TME) that synergizes with immunotherapy to overcome adaptive
resistance. Our objective here is to define and delineate the mechanism(s) of tumor-­specific ROS and DNA
damage induced by β-­lap that stimulates antitumor immunity, and determine how β-­lap synergizes with immune
checkpoint blockade therapy. Our central hypothesis is that (i) β-­lap treatment triggers immunogenic cell death
(ICD) and induces damage-­associated molecular patterns (DAMPs) release;; (ii) phagocytes/antigen-­presenting
cells (APCs) recruitment promotes cross-­priming of cytotoxic T cells (CTLs) for suppression of tumor by
increasing antigen/DNA uptake and type I interferons (IFNs) production;; and (iii) upregulated PD-­L1 within TME
contributes to tumor relapse and provides therapeutic window for combination therapy of β-­lap with immune
checkpoint blockade. We propose the following Specific Aims. AIM 1: Elucidate the mechanism of β-­lap-­
triggered ICD for innate immune sensing. Our working hypothesis is that β-­lap triggers ICD for innate sensing
via the release of DAMPs. We will assess the ability of β-­lap to stimulate tumor ICD in vivo by therapeutic vaccine
assay. We will also determine which type(s) of tumor DNA (genomic or mitochondrial) is the major source(s) of
IFNs production after β-­lap treatment. AIM 2: Define how tumor cells and immune cells cross-­talk occurs
in β-­lap-­induced antitumor immunity. Our working hypothesis is that β-­lap-­induced neutrophils cross-­prime T
cells directly or interact with DCs/macrophages to prime T cells. We will determine the effects of β-­lap treatment
on cGAS/STING/IFNs involved in T cells cross-­priming. AIM 3: Determine the mechanism by which β-­lap
synergizes with immune checkpoint blockade therapy to efficaciously kill NQO1+ tumors. Our working
hypothesis is that increased PD-­L1 within TME contributes to tumor relapse of large tumors after initial responses
to β-­lap. We will determine in which type(s) of cells PD-­L1 expression is upregulated within TME. We will also
determine which type(s) of PD-­L1-­expressing cells is essential for the synergistic effect in mice with conditional
deficiencies of PD-­L1 on tumors, DCs or macrophages. IMPACT: These studies will delineate the role of β-­lap
in tumor-­selective innate sensing that leads to T cell-­dependent tumor control. Further, we will elucidate how β-­
lap overcomes adaptive resistance to anti-­PD-­L1 therapy. This research will provide novel evidence for new
combination therapy for NQO1+ solid tumors and broaden the clinical utility of immune checkpoint inhibitors.

Public health relevance
Title: Targeting NQO1+ tumor to trigger innate and adaptive immunity Project Narrative Defective innate sensing in tumor microenvironment (TME) might contribute to checkpoint blockade resistance. In a new study, we will demonstrate that a tumor- targeting prodrug triggers tumor- selective innate sensing to overcome checkpoint blockade resistance and bridge innate and adaptive immunity. This prodrug will be bioactivated by tumor- enriched enzyme and overcome immunotherapy resistance and eradicate well- established and checkpoint blockade refractory tumors. This study implicates that proper innate sensing inside TME might synergize with T- cell- dependent immunotherapy.